Microcircuit mechanisms behind the distributed cortical contributions to working memory

Project Summary / Abstract
Working memory is the ability to hold and manipulate information in short-term memory in the absence of sensory
input. Recent investigation into the neural underpinnings of this key cognitive ability has highlighted the existence
of distributed working-memory representations across the cortex of macaques and humans. However, we still
do not understand how microcircuits in different cortical areas potentially support their distinct contributions to
working memory. To answer these questions, my laboratory has developed a new working-memory paradigm
for mice navigating in virtual reality, in which short-term memory is temporally disentangled from other task
computations, and its duration manipulated systematically. This will allow for the integration of the unique genetic
and optical toolkits available for mice. Our preliminary data from mesoscale calcium imaging of animals
performing this new task show that the mouse dorsal cortex also contains distributed working-memory
representations. Further, these distributed representations map onto a gradient of spontaneous activity
timescales that increase from sensory to frontal areas. This is such that the primary visual cortex (V1) is active
exclusively during short memory delays, whereas frontal areas such as the premotor cortex (M2) are
preferentially recruited when sensory information needs to be remembered over seconds. Here, we will ask how
genetically identified cell types in V1 and M2 distinctly interact to generate different activity timescales and
patterns of recruitment during working memory. In particular, we will test the hypothesis that differences in the
amount of recurrent excitation and the ratio between inhibition mediated by somatostatin- and parvalbumin-
positive interneurons explain activity patterns during both spontaneous and working-memory behaviors. We will
use simultaneous two-photon Ca2+ imaging and optogenetic stimulation of single neurons to compare how V1
and M2 differentially respond to focal excitatory input. Moreover, we will silence different subtypes of inhibitory
interneurons in each area to understand their role in modulating excitatory activity timescales, measured with
two-photon microscopy or electrophysiology. Finally, to understand how excitatory neurons interact with different
inhibitory-neuron subtypes to result in distinct patterns of task engagement of V1 and M2, we will simultaneously
image from pairs of neuronal types using two-photon microscopy as mice perform our new working-memory
paradigm. Beyond its relevance for basic neuroscience, our work will have translational implications: alterations
in both cortical intrinsic timescale hierarchies and working memory have been reported in normal aging, autism,
and schizophrenia.

Public health relevance
Project Narrative Working memory, or the ability to remember and manipulate information without sensory input, is central to cognitive behavior, but we still do not understand how distributed cortical regions distinctly contribute to this ability. We will combine cutting-edge methods in computational neuroscience, genetics, complex behavior in virtual reality, and simultaneous optical recording and perturbation of neural activity, to understand how microcircuits in two areas of the mouse cerebral hold information on different timescales. Our work has important implications for normal aging, autism, and schizophrenia, all of which have been associated with alterations in both working memory and activity timescales across the human cortex.